A Second Look at DREAM: Towards a New Paradigm in Meibomian Gland Evaluation Using Artificial Intelligence

Project Summary
Dry eye (DE) is a highly prevalent condition with significant impacts on individuals and society that
continues to evade easy diagnosis and treatment. The most common cause of DE is thought to be Meibomian
gland dysfunction (MGD). The Meibomian glands in the upper and lower eyelids secrete lipids that form a thin
film covering the aqueous tears and inhibit their evaporation. In MGD, it is thought that inadequate and/or poor
quality tear lipids are secreted, leading to tear film instability, evaporation, and symptoms of DE. The glandular
changes that occur in MGD are not well understood, nor are we able to identify which aspects of MGD pose
the greatest risk for tear film instability and DE.
The Dry Eye Assessment and Management (DREAM) Study was a clinical trial of ω3 fatty acid
supplements for the treatment of DE. Over the course of the trial a large database of meibography images –
infrared images of the everted eyelids that reveal the Meibomian glands – was compiled and analyzed using a
novel scheme to characterize 13 different aspects of the glands by visual inspection and analyze their
relationships to the clinically assessed quality of the secreted lipids. The process was arduous and time
consuming, inherently subject to human bias, and provided little new information on the links between
Meibomian gland characteristics and DE signs and symptoms.
Recent advances in artificial intelligence (AI) have allowed us to train supervised machine learning
algorithms on meibography images to automatically detect and quantify detailed morphological features of the
individual glands. These detailed morphological features potentially contain a wealth of information about the
health and functioning of the Meibomian glands, and could provide valuable information on the mechanisms
behind MGD and its clinical implications. A further emerging AI technology for use in medical imaging –
unsupervised discriminative feature learning – mitigates the human bias, and could potentially discover
previously unidentified properties in meibography images, and possible links to crucial clinical endpoints like
tear film instability and DE symptoms.
In this project, we propose to utilize this new AI technology to re-analyze the DREAM Study clinical
database of meibography images to dramatically extend their initial findings. Specifically, we will employ
unsupervised discriminative feature learning to mitigate the human bias in meibography analysis, discover
previously unrecognized features of the Meibomian glands, and to analyze the links between these features
and MGD, tear film instability, and the clinical signs and symptoms indicative of DE.

Public health relevance
Project Narrative Dry eye is a widespread and costly condition with significant impacts on quality of life, and is most commonly caused by problems with the lipid-secreting glands in the eyelids called Meibomian glands. In this project we will re-analyze a large database of infrared images of the Meibomian glands compiled during the Dry Eye Assessment and Management (DREAM) clinical trial, and employ artificial intelligence to learn detailed morphological phenotypes of these important glands. The primary goal of this project is to identify the specific pathological features of Meibomian gland dysfunction that lead to tear film instability and dry eye, using a novel artificial intelligence approach to reanalyze previously collected clinical data and meibography images.